The economic and social impact of COVID-19 mitigation policies: A cross-country analysis of macro events

Project Summary The project, The economic and social impact of COVID-19 mitigation policies: A cross- country analysis of macro events, will explore the economic and social effects the mitigation policies and information environment that COVID-19 spawned. We will link those policies to data from ongoing household-based panel studies from 10 countries and rich administrative data from an eleventh. We will exploit the substantial intra and inter-country temporal and geographic variation in non-pharmacological intervention policies induced by the COVID-19 disease. That variation, coupled with pre-COVID baseline levels or long-running trends in the outcomes we will study, will identify the effects of the mitigation policies.

Public health relevance
Project Narrative The project "The economic and social impact of COVID-19 mitigation policies: A cross- country analysis of macro events" will explore the economic and social effects the mitigation policies and information environment that COVID-19 spawned. We will link the policies to individual panel data and exploit the substantial temporal and geographic variation, in and across countries, in non-pharmacological intervention policies induced by the COVID-19 disease.